ELECTROPHYSIOLOGY OF SUPRAOPTIC NEURONS IN VITRO

We propose to utilize a model system, the rat hypothalamo-neurohypophysial explant in vitro, to examine with electrophysiological, immunocytochemical and radioimmunoassay techniques the organization of magnocellular neurosecretory neurons inthe supraoptic nucleus (SON). Our primary goals will be to 1) determine the relationship between electrical activity in SON neurons and vasopressin release; 2) determine the osmosensitivity of SON neurons, its dependence on synaptic input and its relationship to the anteroventral third ventricle; and 3) examine neuronal, ionic and humoral factors influencing phasic, bursting activity, which in vivo is correlated with vasopressin release. Extracellular unit recordings will be made with electrodes filled with horseradish peroxidase (HRP) while changing the composition of the medium and sampling the effluent for correlative changes in vasopressin release. Stimulating electrodes placed on the neurohypophysial stalk will allow the antidromic identification of some of the cells. Media compositions will be varied in the osmolality, drug concentrations and Ca++ and Mg++ proportions to test the role of putative transmitters and synaptic transmission per se in controlling vasopressin cell activity and release. The recording site will be marked with HRP and related tothe distribution of immunoreactive vasopressin and oxytocin neurons. Our long range objective is to understand the mechanisms governing vasopressin release. This hormone is present in all mammals, including man, and dysfunctions in its normal control lead to many clinical syndromes associated with irregularities in sal and water balance, including diabetes insipidus and chronic hypernatremia.